Regulation of angiogenesis by cardiac fibroblasts

Project Summary
Activated cardiac fibroblasts (cFBs) are the primary source of extracellular matrix (ECM) following myocardial
infarction (MI). However, studies suggest that cFBs also regulate neovascularization in the ischemic heart by
expressing pro- and anti-angiogenic secreted ligands. We recently identified that fetal epicardial-derived
fibroblasts express angiogenic factors that facilitate coronary angiogenesis during embryogenesis, which are
also expressed in adult cFBs following myocardial infarction (MI). Specifically, we determined that collagen type
XVIII (Col18a1) and slit guidance ligand 2 (Slit2) were enriched in cFBs compared to cardiomyocytes. Col18a1
sources the anti-angiogenic peptide endostatin, which was downregulated in the border zone of the damaged
heart 7 days post-MI but upregulated in the mature scar at 28 days post-MI. Slit2, a secreted glycoprotein that
binds to roundabout receptors expressed in endothelial cells and pericytes, has been shown to promote
angiogenesis and vessel stabilization and limit fibrosis and inflammation. In the ischemic heart, Slit2 expression
was activated in the border zone and infarct areas 7 days post-MI but quickly downregulated in the reparative
and maturation phases of MI. These data suggest that cFBs coordinate the secretion of angiogenic cues in a
temporal and spatial-specific manner to support cardiac repair; however, the investigation of anti- and pro-
angiogenic factors in fibroblasts has yet to be elucidated. Our central hypothesis is that cardiac fibroblasts
regulate neovascularization by expressing endogenous angiogenic-modifying factors following ischemia. Our
overall objective for this study is to identify mechanisms that increase vascular perfusion and promote positive
clinical outcomes for patients suffering from ischemic heart disease. The following two specific aims will address
our hypothesis: Specific Aim 1. To evaluate the function of anti-angiogenic factors in cardiac fibroblasts following
myocardial infarction. We will assess cFB activation and angiogenic functions in vitro with or without
overexpression of Col18a1 using adenoviruses. For in vivo studies, we will analyze a Col18a1 knockout mouse
following a time course of MI and measure cardiac function, fibrosis, angiogenesis, and coronary and collateral
vasculature formation. Specific Aim 2: To determine if the expression of pro-angiogenic factors alters
angiogenesis and repair following myocardial infarction. The fibroblast-specific Tcf21MCM mouse will be crossed
to Slit2flox/flox mice. We will perform MI, measure cardiac function, and quantify angiogenesis. We will perform
single-cell RNA sequencing on cFBs lacking Slit2 to identify fibroblast-directed programs to enhance
neoangiogenesis. Additionally, we will utilize an AAV9-cTNT-mSlit2-eGFP to express Slit2 in the heart and
evaluate cardiac functional recovery and vascular formation after MI. Overall, accomplishing these studies will
provide an understanding of the cells and molecular signals that enhance vascular perfusion following MI and
guide the development of novel vascular therapeutics.

Public health relevance
Project Narrative Coronary artery disease is one of the leading causes of myocardial infarction, which occurs every 40 seconds in individuals living in the United States. Following a myocardial infarction, increased extracellular matrix deposition by cardiac fibroblasts and the lack of vascular perfusion limits myocardial recovery, eventually leading to heart failure. The proposed research identifies a novel function in cardiac fibroblasts that directs vascular remodeling through the secretion of pro- and anti-angiogenic secreted ligands, supporting the development of new therapeutics to promote cardiac repair following ischemic injury.